Development and Neuroadaptations in Alcohol and Addictions (DNA2)

The goal of this proposal is to renew a highly successful pre- and post-doctoral training program in the area of
development and neuroadaptations in alcohol and addictions (DNA2). Given increasing recognition that alcohol
use disorder and other addictions have roots established in early development, the proposed training grant will
provide the next generation of researchers with crucial training in the conceptual issues and methodological
approaches for studying developmental neuroadaptations leading to substance use and use disorder. Building
on existing research strengths in this area, exemplified by the Developmental Exposure Alcohol Research
Center (DEARC), and anchored by historically strong graduate training programs in development, addictions
and neuroadaptations within the Department of Psychology, the DNA2 program will provide a rich, cooperative
intellectual environment conducive for highly successful research training, didactic education and mentorship
for the proposed predoctoral (4/year) and postdoctoral (2/year) trainees. The training program emphasizes five
key goals: (1) to actively seek and recruit a highly qualified and diverse group of pre- and post-doctoral
trainees whose interest in and commitment to research in alcohol and addictions fits the laboratory(s) of one or
more mentor-eligible faculty and to provide each with an individualized training experience that fosters
expertise in state-of-the-art assessments, hypothesis formation, rigorous experimental design, data acquisition
and analysis, and oral presentation and publication of results; (2) to create a formal training program that
emphasizes breadth in conceptual knowledge and technical capabilities and fosters translational
considerations; (3) to emphasize critical thinking, scientific rigor and best practices for scientists of the 21st
century; and (4) to support the career/professional development of each trainee. To meet these goals, the T32
program will provide comprehensive interdisciplinary training through didactic coursework, trainee workshops,
seminars/colloquia, journal and writing clubs, supervised research experiences, and participation in
professional meetings and extra-university training opportunities. Methodological issues and techniques in
alcohol and drug addiction research will be emphasized throughout the typical 2-year training period for each
trainee, with a particular focus on training in developmental approaches, and rigorous attention to education in
the responsible conduct of research, including means to enhance research reproducibility. This training
program combines the expertise of faculty with established expertise in the alcohol field, as well as in research
with other addictive drugs, to capitalize on synergies across research programs and perspectives.

Public health relevance
Alcohol use disorder and other addictions have their origins in early development; consequently, the next generation of addiction researchers should be trained to conduct rigorous work that uses developmental approaches to characterize antecedents leading to these conditions and strategies to mitigate these outcomes. The T32 training program in Development and Neuroadaptations in Alcohol and Addictions (DNA2) at Binghamton University addresses this critical gap by providing highly qualified pre- and post-doctoral trainees with an interdisciplinary training program that focuses on research into developmental influences on drug and alcohol use and use disorder from a translational perspective.